Training in Health Equity, Highlighting Environmental Inequities, & Growing neighborHood Teachers and Students (YES in THE HEIGHTS)

ABSTRACT:
The mission of this NCI Youth Enjoy Science Training in Health Equity, Highlighting Environmental Inequities, &
Growing neighborHood Teachers and Students (YES in THE HEIGHTS) program at the Herbert Irving
Comprehensive Cancer Center (HICCC) is to reduce the cancer burden and cancer health inequities in the
HICCC Catchment Area (CA) through training and mentoring of students and teachers to increase the diversity
of future cancer researchers. Our program is grounded on the commitment to address multiple levels cancer
causes starting from the social determinants of health (SDoH) and community, household, and individual
chemical and physical environmental exposures that interact with lifestyle and underlying susceptibility. Our
approach emphasizes multiple levels of causation with multiple levels of risk reduction and modification across
the life course including the following themes: (1) SDoH as drivers of cancer health inequities; (2) Multiple levels
of interventions to address the inequities through research, training and dissemination at the community, school,
family and individual level; and (3) Life course approaches to cancer risk reduction that incorporates health
ambassador and citizen scientist approaches and engages high school and undergraduate students in
community relevant health education and field work. We are excited by the opportunity to expand the HICCC
CURE Program through research experiences (Goal 1), curriculum development (Goal 2), and outreach and
engagement (Goal 3). We will continue our commitment to mentoring students in minority-serving institutions,
including students from nearby City University of New York (CUNY), the largest minority-serving undergraduate
university in the U.S. We have also designed the YES in THE HEIGHTS program with novel pedagogical and
experiential training in cancer health inequities and basic science for grade 9-12 science teachers within the Math
and Science for America (MfA) Program. Across all five years, YES in THE HEIGHTS will mentor, train and
engage over 1,125 individuals within the communities we serve. To accomplish these goals, our program will be
grounded on 5 key principles: (1) It takes a village to guide under-represented students through to academic
success; (2) Active mentorship; (3) Foundational training; (4) Team science research; and (5) Program
evaluation. The MPIs Terry and McDonald have successfully run the HICCC CURE program since 2015 and
have extensive background in teaching and mentoring recognized as Mentor of the Year at Mailman School of
Public Health (MSPH) and CU Presidential Teaching Award, respectively. They are joined by a diverse group of
faculty members who have offered to serve as mentors for this R25 program, including 50% women, 21%
underrepresented minority and with diverse areas of expertise including exposure sciences, toxicology,
environmental and molecular epidemiology, participatory research methods and environmental justice, and
biomedical sciences. YES in THE HEIGHTS expands the proven success of HICCC CURE which has trained 50
students since 2015 in research laboratory experiences and over 400 students in online scientific enrichment.

Public health relevance
Narrative The mission of this new NCI Youth Enjoy Science Training in Health Equity, Highlighting Environmental Inequities, & Growing neighborHood Teachers and Students (YES in THE HEIGHTS) program at the Herbert Irving Comprehensive Cancer Center (HICCC) is to reduce the cancer burden and cancer health inequities in the HICCC Catchment Area (CA) through training and mentoring of students and teachers to increase the diversity of future cancer researchers. We will continue our commitment to mentoring students in minority-serving institutions, including students from nearby City University of New York (CUNY), the largest minority-serving undergraduate university in the U.S. and have partnered with Math and Science for America (MfA) Program to develop novel training programs for high school students. Across all five years, YES in THE HEIGHTS will mentor, train and engage over 1,125 individuals within the communities we serve.